Improving Fidelity of Patient-Centered Suicide Prevention Care in Primary Care

This R34 application aims to adapt and conduct pilot work on the Learning through Interactive
Feedback and Training-sUicide Prevention (LIFT-UP) educational program as a strategy to
enhance current implementation strategies. While there are many strategies designed to assist
providers in suicide prevention, they often focus heavily on supporting provider’s delivery of
content, such as lethal means (LM) safety, and ignore developing provider’s skill for how to ask
in a patient-centered manner. Improving the skill by which providers have LM conversations
should in turn increase patient’s willingness to decrease access to LM and increase future
disclosure. LIFT-UP, was developed to support provider’s broad suicide prevention skill
development through the utilization of an algorithmic assessment tool that rates provider’s skill
during a virtual simulation with an actor followed by the provision of structured constructive
verbal feedback. Utilizing recent research on patient perspectives on LM communication and
the Theory of Planned Behavior+Risk Perception, we aim to further adapt LIFT-UP by: 1)
incorporating components attending to patient-centered LM communication through the
alteration of the assessment tool and 2) addressing provider motivation by adding written expert
feedback that shares behavioral strategies to improve, normative information, and patient
outcome awareness. Therefore, Aim 1’s objective is to continue to refine and optimize the LIFT-
UP assessment tool and feedback through obtaining perspectives from: 1a) 32 diverse patients
(i.e., firearm owners, patients with a history of intimate partner violence, patients who use
opiates) on face and concurrent validity of high vs. total scores and specific LM dimensions
using recorded simulations and 1b) 12 healthcare providers on the acceptability,
appropriateness, informativeness, and ability to motivate change of the verbal and written
feedback. After using the information in Aim 2 to make refinements to LIFT-UP (1c), Aim 2
involves a pilot randomized control trial (with crossover) where 50 primary care staff will be
assigned to one of two conditions 1) usual care (UC) or 2) UC plus LIFT-UP. We hypothesize
that the pilot clinical trial will result in providers rating LIFT-UP with high levels of
appropriateness and acceptability and that they will demonstrate increased fidelity to patient-
centered LM skills, be willing to participate in additional LM trainings, and report higher adoption
of LM skills than those who engage in UC alone. Results will inform future work towards a large
cluster randomized clinical trial examining the predictive validity of LIFT-UP’s assessment tool
and the effectiveness of LIFT-UP in enhancing implementation efforts.

Public health relevance
Helping patients reduce their access to lethal means, such as firearms, during times when they are at-risk for suicide is vital. Healthcare systems often focus their efforts on healthcare provider’s talking to patients about this topic. This study seeks to understand if we can utilize an educational program, called LIFT-UP, to enhance primary care provider’s skills in how they talk about lethal means and decreasing access to lethal means among patients at-risk for suicide, rather than only focusing on the frequency of their conversations or the content of what they say.